Directly Converted Neurons as a Novel Cellular Model for ALS and FTD

Modeling human adult-onset neurodegenerative diseases has been historically difficult, with current
induced pluripotent stem cell (iPSC) models often showing mild phenotypes. While iPSC systems capture
disease-associated genetic variants, generating these cells erases cellular age – a critical component of many
neurodegenerative diseases. An alternative approach is the direct conversion of fibroblasts into neurons, which
preserves the epigenetic age of the starting cells. As such, this approach has been highly successful in modeling
pathologies of various neurodegenerative diseases including tauopathies, Huntington’s disease, and Alzheimer’s
disease.
In the proposed research project, we will employ direct neuronal conversion as a new tool to investigate
amyotrophic lateral sclerosis (ALS) and associated frontotemporal dementia (FTD). We will initially study familial
ALS cells that have been converted into induced motor neurons and subsequently probe for neurodegenerative
phenotypes. We have already observed stress-induced degeneration in the context of multiple ALS-associated
mutations. Removal of epigenetic age via iPSC conversion and antisense oligonucleotide knockdown of mutant
proteins will establish the specificity of this system. We will further expand our studies to sporadic ALS lines,
investigating neurodegeneration-associated features including nuclear pore deficits. Finally, cells from ALS/FTD
patients will be converted into a cortical identity to provide a novel model for FTD. With these models, we can
interrogate disease mechanisms in ALS/FTD. Further, the development of a tractable, patient-derived in vitro
model of familial and sporadic ALS would represent a considerable breakthrough for the ALS research
community, facilitating the eventual development of novel therapeutic agents.

Public health relevance
Modeling human amyotrophic lateral sclerosis (ALS or Lou Gehrig’s disease) has been challenging, with current stem cell-based and animal systems showing mild or limited phenotypes. The lack of models that recapitulate disease phenotypes impedes the development of much needed therapies. Here, we aim to establish direct fibroblast-to-neuron conversion, which preserves epigenetic age, as a novel system to understand human ALS and associated frontotemporal dementia.